Multiomic single cell and spatial interrogation of mechanisms in cellular adaptation to stress

ABSTRACT
The parent award aims to study transcriptional and epigenetic mechanisms of cellular survival and adaptation
under stress using lineage barcoding, single-cell multiomics, and spatial transcriptomics. Budget cuts have
limited the number of cancer models and cell lines studied, potentially impacting the generalizability of the
findings. This Equipment Supplement requests funds to purchase an Element AVITI System, a transformative
next-generation sequencing platform that will overcome these limitations and enhance the impact of the parent
award. The AVITI System's unique Avidity Base Chemistry delivers high-quality sequencing data while
dramatically reducing costs. Its acquisition will enable lineage tracing and sequencing on more cancer models
and stressors, improve data quality for precise barcode assignment, and accelerate experimental workflows.
We are requesting $250,000 towards the total cost of $290,000, with the Shaffer lab covering the remaining
$40,000 (see letter). This purchase will have the greatest impact on the research if supported now at the start
of the award. The AVITI System will be housed in the Shaffer lab, which has extensive experience in operating
similar equipment. Cost savings from transitioning to the AVITI platform will allow the project to achieve more
of its initial goals without exceeding the sequencing consumables budget. Long-term sustainability for the
service contract expenses will be ensured through cost-sharing agreements with other labs, UPenn Institutes,
and departments.

Public health relevance
PROJECT NARRATIVE The parent award research aims to understand how cells survive and adapt under stress, which could lead to new treatments for cancer and other diseases. By acquiring a benchtop sequencing instrument, we will be able to study these cellular responses more comprehensively and cost-effectively, accelerating our progress towards identifying novel therapeutic targets to enhance health and reduce illness.